DEVELOPMENT OF AN AUTOMATED CARTRIDGE-BASED BREAST CANCER DETECTION ASSAY- AN ACADEMIC-INDUSTRIAL PARTNERSHIP

Abstract. In many low- and middle-income countries (LMICs) breast cancer is diagnosed at advanced stages.
Many women present with a palpable breast mass, which is rare in communities where breast screening is
available. In addition to limited imaging facilities, prolonged diagnostic delays (76-630 days) due in part to the
extreme shortage of pathologists (as few as 1 per million/population) contribute to a 5-year mortality rate up to
4 times higher than that in the US. An innovative solution to this problem could be an affordable, easily deployable
molecular test to identify and prioritize women likely to have a malignancy for expedited biopsy and pathology
review. It is well established that early detection of breast cancer improves survival. With our industrial partner,
Cepheid, we propose to build on our published breast cancer detection prototype to develop an affordable, <3-
hour, automated breast cancer detection (aBCD) assay that analyzes a panel of hypermethylated genes in breast
fine needle aspirates (FNAs).The proposed innovations will cut the assay time in half, and reduce costs by at
least 3-fold to provide a single-cartridge assay for quick cancer detection. In Aim 1a, we will optimize the
Offboard bisulfite-mediated DNA conversion method and test its efficiency in Patient Set 1 FNAs (N= 29
malignant, 25 benign). In Aim 1b we will select one optimal 5-marker panel and test its performance using first,
the gold standard, FFPE samples (N= 30 malignant, 30 benign), and then, Patient Set 2 FNAs (N=35 malignant,
35 benign). In Aim 1c, we will perform technical validation of the aBCD assay. Intra-assay reproducibility will
be assessed on multiple sample collections of Patient Set 3 FNAs (N=30 malignant, 30 benign). Inter-operator
reproducibility will be determined using replicate FNA slides from Patient Set 2 (N= 35 malignant, 35 benign).
The goal of Aim 2a is to perform clinical validation of the aBCD assay. We will first select a threshold in a
Training set of FNAs: Patient Set 4 (N=100 malignant, 100 benign) to optimally balance sensitivity and specificity,
and validate performance of the selected threshold in a Test set of FNAs: Patient Set 5 (N= 180 malignant, 180
benign). We will measure the accuracy (sensitivity, specificity, and positive- and negative-predictive value) of
aBCD-based diagnosis to distinguish benign versus malignant lesions using histopathological diagnosis of the
core biopsy as the gold standard. Lastly, in Aim 2b, to determine whether select patient characteristics alter the
performance of the aBCD assay, we will test its clinical accuracy among specific patient subgroups based on
age, race, BMI, and tumor characteristics (grade, stage, tumor subtype). All these steps are necessary to ensure
an accurate and reliable test. This intervention is paradigm shifting, and could revolutionize the current detection
of breast cancer in underserved regions of the world by expedited treatment and, in turn, saving thousands of
lives yearly. This study will also facilitate further development of the aBCD assay toward commercialization,
making it accessible globally.

Public health relevance
Project narrative We propose a path to commercialize an affordable, automated breast cancer detection (GeneXpert® BCD) assay that analyzes our published, hypermethylated gene panel in fine needle aspirates of palpable breast lesions to rapidly detect malignancy, for use in low- and middle-income countries. In collaboration with our industrial partner, Cepheid, and our clinical team in South Africa, we will analytically and clinically validate the assay for future commercialization. Innovative approaches to increase early detection and decrease treatment delays of breast cancer can save thousands of lives in the many resource-poor areas of the world.